Biochemistry of Eukaryotic Replication Fork and DNA Repair

Project Summary
DNA replication is performed by numerous proteins that act as a dynamic machine, termed a replisome. The
core components of the eukaryotic replisome consist of 1) an 11 subunit “CMG” helicase that separates the
parental DNA strands, 2) The leading and lagging strand DNA polymerases (Pol), Pol d and Pol e,
respectively,3) The PCNA sliding clamp that encircles DNA and tethers both Pols to DNA for high processivity,
4) the RFC clamp loader pentamer that loads PCNA onto DNA and 5) Pol a-primase that makes a hybrid RNA-
DNA primed site for the Pols to initiate DNA synthesis. In addition to these “core” components, there are
several ancillary proteins including RPA, Tof1, Mec1, Csm3, FACT, Mcm10, Ctf4, Ctf18-RFC. There are a host
of proteins that assemble two CMGs around duplex DNA at origins. The CMG dimer unwinds the closed
duplex in an unknown reaction and scaffolds enzymes to assemble replisomes. We have purified these
proteins in the yeast (Saccharomyces cerevisiae; S.c.) system. In this proposal, we will extend our studies on
the structure/function of the eukaryotic replisome. We will use biochemical and single-molecule methods to
determine if PCNA accumulates on the lagging strand as expected, and whether PCNA may periodically be left
on the leading strand for mismatch repair and assembly of naïve nucleosomes. We have solved numerous
structures with our collaborator, Huilin Li (VanAndel Institute, MI), and have many more structures in progress
and planned. We have purified the several factors of the ATR DNA damage checkpoint signaling system of
which many replisome proteins are targets of this pathway. We plan biochemical studies that will clarify targets
and their effect on replisomes. We will determine the mechanism of nucleosome inheritance during replication.
In metazoans, epigenetic inheritance of nucleosomes, gone awry, can lead to cancer and other diseases. In
yeast, cell studies have shown that a Mcm2 histone binding mutant prevents epigenetic transfer to lagging
strands, and Pol e lacking the Dpb3/4 subunits does not transfer epigenetic marks to the leading strand. We
plan to visualize nucleosome transfer during replication in real time using single-molecule studies with our
newly acquired Q trap) in collaboration with Dr. Shixin Liu (Rockefeller University)). We have various
nucleosome mobility factors and yeast nucleosomes having different fluorescently tagged histones for these
studies. Replication occurs in nuclear foci, having “replication factories” with many DNA replication forks. Our
recent biochemical and structural studies have defined the composition and atomic structure of the most basic
unit of a replication factory, a dimeric replisome. We will employ super resolution microscopy to validate if our
reconstituted factory is the same as that inside cells. We have insight into how duplex DNA at origins is opened
into single strands from our recent finding that the twin CMG helicases encircling duplex DNA at an origin are
directed inward, opposite the “outward” direction thought for a decade. We find that two inward directed CMG
can shear DNA apart. We have plans to further this line of investigation.

Public health relevance
Project Narrative DNA replication, the duplication of the cell’s genetic material, requires over 3 dozen proteins to orchestrate this complex process and any of these processes gone awry can lead to human disease, including metastatic cancer. The studies proposed here are basic studies using pure proteins to understand very specifically on how these many proteins function together to duplicate DNA, but with an eye toward processes that may lead to human abnormal function, especially for epigenetic inheritance that is known to cause human disease. However, there are certainly other disease related processes that will come to light as the basic mechanism of how the replication machinery functions.